Cincinnati Rheumatic Diseases Resource Center

Project Summary / Abstract - Overall
The central goal of the Cincinnati Rheumatic Disease Resource Center (CRDRC) is to promote studies that
advance the understanding of pediatric rheumatic diseases and lead to new therapies for these diseases. The
Cincinnati Rheumatic Disease Resource Center has two specific aims. Aim 1: Provide resources that will
enhance the scope and breadth of the research community to advance the central focus of understanding
inflammation and biological mechanisms contributing to the development of rheumatic disease in children and
adults. Aim 2: Foster collaborations and interdisciplinary approaches to promote laboratory discoveries and
generate translational research opportunities that lead to important patient-oriented outcomes. The Cincinnati
Rheumatic Disease Resource Center includes an Administrative Core and four Resource Cores:
· Pediatric Rheumatology Tissue Repository (PRTR) Leader, Grant Schulert, MD, PhD
· Integrative Cell Phenotyping Core (ICPC). Leader, Sherry Thornton, PhD
· Functional Genomics Core (FGC). Leader, Leah Kottyan, PhD
· Bioinformatic and Modeling Core (BAM). Leader, Matthew Weirauch, PhD
Collectively, these resources form a powerful infrastructure that fosters development of precision and predictive
medical approaches based on genomics and disease mechanisms. The CRDRC will support disease-based
research across the continuum of discovery, where laboratory findings generate translational studies that lead
to clinical trials. In addition to advancing knowledge of pediatric rheumatic disease, the goals of the CRDRC
include recruitment of established investigators to bring new expertise to the field, cultivation of collaborations
within the local and national research community, and encouragement of young investigators committed to
pursuing research careers focused on pediatric rheumatic disease. These goals of the CRDRC are particularly
well supported by a Pilot Study Program that includes funding of work within the P30 cores and extends to
institutional cores to broaden impact and support new areas of investigation. The CRDRC also will strengthen
the research community through an enrichment program of local seminars, workshops, and symposia. A highly
accomplished and collaborative community of researchers is already in place with expectations of major growth
through new recruitment. An innovative Visiting Scholars program will aid in the dissemination of innovative
approaches and the enrichment of faculty and trainees who are from groups historically underrepresented in
medical research. Together, these attributes create fertile ground for accomplishing the goals of the CRDRC,
and ultimately to accelerate research to benefit pediatric rheumatic disease patients in their care.

Public health relevance
Project Narrative - Overall The Cincinnati Rheumatic Diseases Resource Center will promote biomedical research that yields insights into fundamental processes and pathogenic mechanisms of rheumatic diseases in children. This will be done by coordinating resources and core services as well as promoting interdivisional, interdepartmental, and national collaborations.